Regulation of cardiomyocyte growth in a fetal ovine model of reduced left ventricular filling

PROJECT SUMMARY / ABSTRACT
Cardiomyocytes are the working muscle cells of the heart, and their number is intrinsically tied to heart function
and resilience. Too few increases the stress on each cardiomyocyte, leading to pathological changes and a
vicious cycle of cell death and fibrosis. In hypoplastic left heart syndrome (HLHS), the right ventricle (RV) is the
single working ventricle for life. This puts a lot of stress on the cardiomyocytes, often leading to heart failure
early in life. Given that the RV is expected to do twice the usual work in these hearts, the usual number of
cardiomyocytes is too few in HLHS. The goal of this proposal is to investigate how the cardiomyocytes of the
fetal heart with reduced left ventricular inflow grow differently than normal, whether by proliferation,
hypertrophy, or apoptosis. This information will help us to develop therapies to increase cardiomyocyte number
in hearts of these most vulnerable infants. Although prior studies by experienced investigators have not
perfectly modeled clinical HLHS, each has added new and important information. We have newly established a
fetal sheep model of impaired left ventricular inflow, similar to the hemodynamic pathology of HLHS.
Comparing fetal sheep chronically affected by impaired left heart inflow versus those with normal
hemodynamics, we will assess changes in the physical and hormonal factors that we know regulate
cardiomyocyte growth, maturation and survival before birth. We will then look at the hearts themselves to
determine how they have grown, and how they function. We will study the cardiomyocytes to understand their
contribution to heart growth, and to test how they respond to the regulatory factors changed in the fetus.
Finally, we will test ways to intervene and increase cell number in the heart of the fetus with reduced LV inflow.
Ultimately, this work will help optimize cardiomyocyte number in babies with HLHS in order to strengthen their
hearts for life-saving surgery and make them more resilient against heart failure for life.

Public health relevance
PROJECT NARRATIVE This project is designed to fill a gap in our understanding about how the muscle cells of the right ventricle grow in fetal hearts with reduced left ventricular inflow, as occurs in hypoplastic left heart syndrome, and how we can improve this growth. Completion of the project will help us know and shape the forces that determine the cardiomyocyte endowment of the right ventricle, which is destined to be the systemic ventricle for life.